Core C: Imaging-Abou Alaiwa

CORE C – IMAGING
PROJECT SUMMARY
Cystic fibrosis (CF) is a common autosomal recessive disease caused by mutations in the gene encoding the
cystic fibrosis transmembrane conductance regulator (CFTR). CF affects multiple organs, including lungs,
pancreas, intestine, liver, sweat glands, gallbladder and the male productive tract. Airway infection and
inflammation currently cause most of the morbidity and mortality. Although several therapies have improved
the lives of patients, current treatments are inadequate and CF remains a lethal disease. Our knowledge
about the pathogenesis and the progression of the disease, as well as the state of the neonatal lung is
inadequate. These gaps in our knowledge have hindered attempts to develop better treatments and
preventions for CF lung disease. A major impediment to addressing these issues has been limitations of
current animal models. CF pigs replicate many of the key features of human CF disease including intestinal
obstruction, exocrine pancreatic destruction, micro-gallbladder, vas deferens abnormalities, focal biliary
cirrhosis, congenital airway structural abnormalities, and airway and sinus infection with time. The Imaging
Core has two main objectives: (1) Provide scientific support, expertise, and resources for acquisition of image
datasets and subsequent analysis; and (2) Help Project Leaders successfully accomplish the aims of their
Projects. State-of-the-art image acquisition technology and analysis tools are readily available at the
University of Iowa for these Projects. The Imaging Core will function seamlessly through already established
interactions with the Project Leaders, Core Directors, the Translational Lung Imaging Research Program, and
the Iowa Comprehensive Lung Imaging Center.

Public health relevance
CORE C – IMAGING PROJECT NARRATIVE Cystic fibrosis is a common life-shortening disease that causes progressive lung failure due to recurrent infections and chronic inflammation. These studies will use novel animal models and advanced imaging modalities to understand normal lung defenses and the derangements produced by CFTR mutation at the onset and with progression of the disease. These studies will also help develop better therapies for cystic fibrosis lung disease.